The preferred retinal locus in central vision loss

PROJECT SUMMARY/ABSTRACT
People who lose their central vision due to macular disease such as age-related macular degeneration
(AMD) must use their residual peripheral vision for visual tasks. Following the onset of central vision loss, most
patients eventually adopt an eccentric retinal location outside the affected macular area, the preferred retinal
locus (PRL), as their new reference locus for visual tasks. Little is known as to how and why a location eventually
evolves into the PRL. In this project, we are going to tackle the what, where, why, how, who and when of the
PRL development. The long-term goals of this project are to understand the mechanism(s) underlying the
development of the PRL, and the limiting factors and potentialities of the PRL(s) for various visual tasks so that
effective visual rehabilitative strategies can be developed for patients with central vision loss.
The first aim of the proposed research addresses the what question. We hypothesize that there is a shift
in the origin of the retinotopic reference frame from the fovea to the PRL for people with central vision loss. We
will determine the retinal locus used to perform oculomotor and perceptual tasks to evaluate if the retinal locus
for these tasks is shifted to a consistent location outside the scotoma with properties similar to those of the fovea.
The second aim addresses the where and why questions. We hypothesize that the PRL is the location
with the most optimal retinal structures/functions. Optical coherence tomography and adaptive-optics imaging
will be used to measure structural properties; and acuity and sensitivity will be measured around the scotoma of
participants with central vision loss. We will determine if these structural properties can predict the PRL location.
The third aim addresses the how question. We will test the hypothesis that vision at the PRL can be
optimized for people with central vision loss. We will measure wavefront aberrations to determine the best
spectacle prescription that corrects for optical aberrations to test if this will improve visual performance for our
participants. We will also devise a perceptual learning and a saccade training task to determine the effectiveness
of these training regimes on improving the functional vision of our participants.
The fourth aim addresses the who and when questions. We will track the changes (if any) of the structural
properties in the macular region over a period of three years in a cohort of participants with early AMD who do
not yet have a PRL, with the expectation that a subset of these participants will eventually develop a PRL, thus
allowing us to identify who will develop a PRL and the time-course of the PRL development.
Findings from this project will tell us more about the PRL — what it really represents, where it is, why a
particular location evolves into the PRL, how vision can be improved or enhanced at the PRL, who will develop
a PRL and the time-course of the development (when). The information combined have the potential of
developing into useful rehabilitative tools that might help us predict the best location for a PRL or improve the
functional vision of people with central vision loss.

Public health relevance
PROJECT NARRATIVE Following the loss of vision in the macular area, most people with macular disorders such as age-related macular degeneration (AMD), Stargardt disease and other disorders adopt a retinal region outside the macular area as their “surrogate fovea” — the preferred retinal locus (PRL). The long-term goals of this project are to understand how the PRL develops, its properties in relation to visual processing, and the limiting factors and potentials for improving vision for people with central vision loss. Findings of this research project will provide the sorely needed information for the development of promising and more effective rehabilitation strategies for people with central vision loss.